Towards Universal Chemosensory Testing

PROJECT SUMMARY
The COVID-19 pandemic has brought smell and taste dysfunction to mainstream attention. Despite its role in
signaling disease, as well as safety, attachment, and quality of life, the diagnosis of chemosensory disorders is
far from accessible for most patients or routinely employed by most health care providers. Aligned with the
goals of the 2022-2027 draft of the NIDCD Strategic Plan, we propose a conference to bring together
scientists, clinicians, public health officials, patients and all other interested parties to identify opportunities and
challenges for implementing routine chemosensory testing nationwide. The organization and execution of the
conference result from a collaborative effort of four leaders with diverse backgrounds in the science and clinical
application of chemosensory testing who represent institutions with distinct expertise in these areas.
Participants in this conference will (i) share state-of-the-art methods in chemosensory testing; (ii) identify
benefits and practicalities of chemosensory screening both for individuals and at the population level; (iii)
communicate this information to medical associations, health care professionals, academic institutions,
governmental agencies, insurance companies, industry, and the general public; and (iv) produce a peer-
reviewed, consensus white paper for universal chemosensory testing detailing the rationale and
recommendations that emerge from the conference, including a strategy to produce guidelines modeled on
other successful campaigns. This in-person conference will include virtual components and childcare
assistance, thus enabling the wider participation of diverse groups. We will also make videos of the
presentations available online and generate Plain Language materials for the lay public, with both Spanish and
English, as outreach content. Together, these activities will advance the use of chemosensory testing in
multiple contexts, to speed diagnosis of chemosensory disorders and associated health problems, facilitate
therapeutic and supportive interventions for affected individuals, and improve human health and quality of life.

Public health relevance
NARRATIVE People with dysfunctions of smell and taste experience disrupted connections with their surroundings, including family and friends, food, and the environment. This compromises diet and nutrition, increase risk from environmental hazards (e.g., fire, gas leaks, and spoiled food), and significantly reduces positive mood and quality of life. Chemosensory disorders can also signal several health conditions, including infections and neurodegenerative diseases. Currently, routine clinical evaluation of smell and taste is rare; it is critical to develop a consensus roadmap to integrate chemosensory testing into regular health care.